Planning Advance Care Together (PACT) to Improve Engagement in Advance Care Planning among Advanced Cancer Patients

PROJECT SUMMARY/ABSTRACT
Engagement in advance care planning (ACP), which includes having end-of-life (EoL) conversations and
completing advance directives (ADs) (e.g., living will, health care proxy), has been shown to improve the
quality of care and reduce suffering at the end of life. However, less than half of advanced cancer patients
engage in ACP or complete ADs. One commonly overlooked barrier to ACP engagement and AD completion is
a lack of acknowledgment that the majority of cancer patients report ACP as a social process in which they
want to engage multiple loved ones and family members in their decision-making process. Dr. Shen's prior
work suggests that patients frequently report involvement of family members as a critical concern and need for
engaging in ACP and that 70.7% report their EoL care treatment preferences being shaped around concerns
about their family members. Based on this pilot work and prior work indicating a patient preference to engage
in ACP as a social process, this study aims to develop and pilot test a website [Planning Advance Care
Together (PACT)] designed to improve advanced cancer patients' and caregivers' engagement in patients'
ACP, presence of ACP discussions, completion of ADs, and receipt of goal-concordant care. The goals of this
study are to: (1) refine and field-test a mobile application intervention (PACT) using an iterative design
approach, “Think Aloud” exercises, and usability protocols; (2) evaluate the feasibility, acceptability, usability,
satisfaction, and user engagement of the intervention among advanced cancer patients and their caregivers;
(3) test the preliminary efficacy of the intervention on patients' and caregivers' level of engagement in ACP,
documented ACP conversations, and patients' completion of ADs (primary outcomes); and patients' and
caregivers' perceived social support and family functioning as well as patients' receipt of goal-concordant care
(secondary outcomes); and (4) evaluate process measures in a post-intervention interview. An added
proposed extension aim is to conduct a process evaluation to identify multi-level barriers and facilitators as well
as best pathways to implementation of PACT. To achieve this newly proposed aim, we will conduct 16 focus
groups (5 participants each) with patients with advanced cancer (n=20), caregivers/support persons of patients
with advanced cancer (n=20), providers (oncologists, nurses, palliative care, psychologists, social workers)
(n=20), and healthcare system leaders (n=20) to identify barriers, facilitators, and best pathway(s) for
implementation (embedding within EPIC/MyChart, direct referral from providers, and/or direct-to-consumer
marketing). Grounded in established theories of decision-making science, the proposed project takes the novel
approach of utilizing web-based health technology to integrate loved ones into patients' ACP decision-making.

Public health relevance
PROJECT NARRATIVE The proposed research is consistent with broader public health goals focused on improving patient end-of-life care and the College of Surgeons Commission on Cancer and Centers for Medicare and Medicaid Services (CMS) call for increased patient engagement in advance care planning (ACP) as part of standard care. The proposed study will address this public health issue by developing, pilot testing, and determining best dissemination and implementation practices for a website (Planning Advance Care Together, PACT) designed to improve advanced cancer patients' levels of engagement in ACP, documented ACP conversations with doctors and family members, completion of advance directives, and receipt of goal-concordant care by integrating support persons (i.e., “caregivers”) and providers into the ACP decision-making process. Therefore, this study is aligned with the NCI's long-term goals of improving quality of care at the end of life and the CMS's goal of improving engagement in ACP.